Defining New Pathways for Complex Human Heart Failure and Arrhythmia

Project Summary
Normal cardiac function requires synchronization of structural and electrical molecules within the heart.
Defects affecting cardiac excitability linked to sudden cardiac death affect ½ million people, and those affecting
contractile function, such as in the case of cardiomyopathy, impact another 5.7 million patients in the U.S. each
year. However, often overlooked are cardiovascular (CV) phenotypes that result in both electrical and contractile
dysfunction. This relationship between contractile and electrical elements is critically important to understand in
the patient with congenital heart disease (CHD). There are now more adults (ACHD) living with CHD than
children, and in this population the most common late manifestation of CHD is a severely complex phenotype
hallmarked by both heart failure and arrhythmia. The ACHD community recognizes the importance of each of
these entities, and has set forth high-priority areas of study surrounding heart failure and arrhythmia, with the
goal of using models aimed at the ‘cellular keystones underlying CHD’. This proposal embraces that focus,
shifting from the study of each of these late CV sequela independently, and taking a broader look at the complex
CHD phenotypes that result in both electrical and contractile dysfunction. We have identified a molecule which
we believe has both CV electrical and contractile consequences, thereby serving as a good foundational model
to study complex phenotypes resulting in combination arrhythmia and heart failure. Ankyrins are a membrane-
associated protein directly linked with targeting ion channels in myocytes, neurons and other excitable cells. In
heart, ankyrins-B and –G, which function to support myocyte actin/spectrin in the cytoskeleton and function in
cellular organization, transport, gating and post-translational modification, are associated with critical membrane
ion channels. Canonical AnkG is required for normal NaV1.5 channel targeting in the heart. However, we have
identified a novel ‘giant’ cardiac ankyrin-G isoform that we implicate is critical for normal cardiac structure,
contractility and electrical conduction. Mice lacking ‘Giant AnkG’ display a dilated and thinned left ventricle with
reduced systolic function, consistent with a dilated cardiomyopathy phenotype. These same mice also exhibit
electrical dysfunction including ventricular arrhythmia and high-degree heart block. Our new preliminary data
support our central hypothesis: A single ankyrin gene produces two separate molecules- each with unique roles
in cardiac structural and electrical function. We hypothesize that novel cardiac Giant AnkG functions via a unique
sodium-channel independent mechanism leading to regulation myocyte structure, membrane organization and
abnormal intra- and inter-cellular signaling. Ultimately, loss of function of this large gene product leads to altered
myocardial contraction and defective electrical function.

Public health relevance
Project Narrative Despite improvements in cardiovascular care, heart failure and arrhythmia remain the most common late manifestations of heart disease, and are poorly defined in heritable/congenital heart disease populations. Therefore, the identification of new pathways underlying heart failure and arrhythmia are essential to better assess risk, improve diagnostic evaluation, and change the natural history of this disease. Our proposal will test the role of novel Giant AnkG in cardiac function and dysfunction.